Leveraging metabolomics to identify factors contributing to health disparities in Native Hawaiian individuals

1
2 Native Hawaiian individuals represent one of the most underserved and understudied populations in US
3 healthcare and medical research. However, this population is one of the fastest growing in the US and faces
4 alarming long-standing health disparities, with approximately 30% higher risk of cardiovascular disease, 100%
5 higher risk of diabetes and gout, and 400% higher risk of stroke compared to White individuals. Obesity and high
6 body mass index (BMI) are known to increase risk for these conditions, and notably, an estimated 41% of Native
7 Hawaiians are obese compared to 21% of White individuals. Native Hawaiians are characterized predominantly
8 by Polynesian, European, and East Asian ancestries, and higher Polynesian ancestries in Native Hawaiians
9 have been linked to higher risk of hypertension, type 2 diabetes, and heart failure, as well as higher BMI and
10 subcutaneous and visceral fat, even after accounting for socioeconomic and smoking status. Despite Native
11 Hawaiians sharing East Asian ancestry with Japanese individuals, the burden of some of these conditions are
12 lower in Japanese Americans. As many of these health disparities are cardiometabolic in nature, the objective
13 of this research is to evaluate circulating metabolomic profiles in Native Hawaiians and Japanese Americans,
14 given their complementary risk profiles, to illuminate the underlying mechanisms contributing to health disparities
15 in these populations. This will be accomplished by establishing a large-scale high throughput metabolomic
16 resource in 2,000 Native Hawaiian and 1,000 Japanese American participants from the Multiethnic Cohort. In
17 Aim 1, we will conduct genome-wide association studies (GWAS) and evaluate genetic ancestry to investigate
18 the contribution of genetics to metabolite variation. In Aim 2, we will conduct metabolome-wide association
19 studies to identify metabolites associated with cardiometabolic and other health-related traits presenting health
20 disparities in Native Hawaiians. In Aim 3, we will investigate potentially causal metabolic mechanisms impacting
21 health-related traits, leveraging the full sample of 5,660 Native Hawaiian and 24,485 Japanese MEC participants
22 with GWAS data, along with GWAS summary statistics from >14,000 Pacific Islander and >214,000 Japanese
23 participants across multiple studies. Findings from this investigation are expected to substantially improve our
24 understanding of the underlying mechanisms contributing to cardiometabolic and other health-related conditions
25 presenting health disparities in Native Hawaiian and Japanese American populations, which will ultimately
26 contribute to novel means to reducing these disparities. This study will also importantly bolster innovative
27 epidemiologic research to address major knowledge gaps and health disparities in populations that are
28 understudied and when included in research, often studied in aggregate, masking the ability to identify distinct
29 etiologic factors.
PROJECT SUMMARY

Public health relevance
PROJECT NARRATIVE Native Hawaiian individuals represent one of the most underserved and understudied populations in medical research despite being one of the fastest growing populations in the US and facing alarming long-standing health disparities, many of which are metabolic in nature. In this study, we will generate large-scale metabolomic data in this population and Japanese Americans, who have complementary risk profiles compared to Native Hawaiians, to investigate genetic factors contributing to metabolic profiles in these populations and metabolic factors that contribute to the health and health disparities of these populations. This investigation will greatly bolster epidemiologic research in these understudied populations, and findings are expected to have important implications for mitigating health disparities.